Fis1 Regulation of Mitochondrial Fission

The goal of this administrative supplement request is to provide needed upgrades to a Nikon
spinning disc confocal microscope screening for studies on mitochondrial fission proteins for
R01GM067180. Altered mitochondrial fission has severe consequences even death. Yet the
reasons for this are unknown. It is postulated that the mitochondria have their own lifecycle that
involves fission of unhealthy mitochondria to remove them. In this model, the proper balance of
fission is critical: either excess or impaired fission result in unhealthy mitochondria. This model is
compelling because it explains how alterations in fission can cause or contribute to many
fundamentally different diseases including recovery from heart attack and stroke, increased
metabolic stress from diabetes, normal aging, and neurodegenerative diseases such as
Parkinson's and Alzheimer's disease. To determine this, we have generated several mutants,
many of which are pathological. We are testing hypotheses by determining how these mutants
impact biomolecular interactions inside cells. The requested instrumentation will greatly
accelerate our work as it allows for faster data collection and analysis including the use of cutting-
edge machine learning tools. Detailed microscopic information will provide a better understanding
of the protein machinery and how it works, which will identify key points of regulation that may be
targeted with small molecules to inhibit, and activate, fission. The discovery of such molecules
may ultimately lead to treatments for diseases in which enhanced, or impaired, fission is central.

Public health relevance
Mitochondria are components of cells that perform many functions critical for life and are known for being the "power plant" of the cells. The mitochondria have their own life cycle with a mechanism to destroy damaged mitochondria that involves a splitting event that separates a healthy daughter mitochondrion from an unhealthy one that is subsequently removed by the cell. The work proposed will illuminate mechanistic details of these processes and represents an important step towards the discovery of new therapeutic strategies for both rare and common human diseases, including cardiac and neurodegenerative diseases, cancer, diabetes, aging, and neonatal lethality syndrome.